Molecular and Circuit Pathogenesis of Alcohol Addiction

This NIAAA Alcohol Research Center (ARC) Grant is the catalytic element that integrates a large group of
investigators across the University of North Carolina at Chapel Hill (UNC). The UNC School of Medicine
Bowles Center for Alcohol Studies (BCAS), provides a foundation of administrative support and dedicated
Bowles building space for alcohol research. The UNC ARC fosters interdisciplinary collaborative research on
alcohol use disorders, alcohol abuse and the impact of alcohol on health and disease - exactly the goal of an
NIAAA ARC. The ARC has facilitated the growth and development of UNC into an outstanding alcohol
research University, among the best in the world. Research and education have always centered on a theme
of molecular and cellular pathology in alcohol use disorders. This renewal focuses on the molecular
mechanisms that underlie alcohol-induced circuit pathology across the stages of addiction. Ultimately, our
guiding hypothesis is that alcohol-induced dysregulation of neural circuitry drives pathological behaviors and is
thus the key cause of all alcohol-related pathology.
This 4th renewal of the UNC ARC continues an emphasis on alcohol use disorder pathology, integrating
existing and new faculty to investigate changes in neural circuits and molecular signaling in models of drinking
across the proposed stages of addiction. The scope of these studies addresses the critical neurobiological
changes leading to all alcoholic pathologies, i.e. the mechanisms leading to heavy chronic drinking. The ARC
integrates multiple signaling systems and neurocircuits that each focus on specific mechanisms within and
across brain regions. The research components also include the translational endpoint, functional magnetic
resonance imaging (fMRI) connectivity of each component’s pathological circuit model in the Scientific
Resource Core. This approach is expected to increase discovery, improve models and gain strength from
common assessments across preclinical models to the ARC human studies. The ARC through the Information
Translation Core informs practicing health professionals, health professional and college students as well as
youth through specific alcohol curricula for each group to have the greatest impact on health. This proposal
connects principle investigators of involving 15 independent funded faculty. By design, each research
component of this ARC will focus on specific models that capture distinct endophenotypes associated with
alcohol abuse. A range of molecular mechanisms that drive these circuit alterations will be explored, including
kinases, cytokines and neuropeptides. This ARC renewal continues to be the catalytic element that integrates
a broad group of investigators, pairing senior and junior faculty within ARC components that promote discovery
across the BCAS and UNC as well as educating many within NC.
This ARC proposal continues a research focus on pathogenesis of alcohol addiction with emphasis on
molecular and circuit mechanisms that lead to dysfunctional brain networks, a theme at the cutting edge of
neuroscience. The ARC will conduct, promote, support, and mentor research on the pathology of alcohol use
disorders and educate broad groups of the public, including health professionals, families, college students and
youth in North Carolina on the causes and prevention of these disorders.

Public health relevance
The University of North Carolina Alcohol Research Center will conduct, promote, support, and mentor research on the pathogenesis of alcohol use disorders and educate broad groups of the public, including health professionals, families, college students and youth in North Carolina on the causes and prevention of these disorders.